Tumor-specific anti-angiogenic anti-CD70-FGF/VEGF-trap fusion antibodies for renal cancer therapy

PROJECT SUMMARY
Renal cell carcinoma (RCC) is a lethal disease whose incidence is on the rise. It is categorized into various
subtypes, with clear cell RCC (ccRCC) representing about 85% of all RCC tumors. Current targeted molecular
strategies, including tyrosine kinase inhibitors (TKIs), have resulted in a doubling of progression-free survival
and significant gains in overall survival in ccRCC patients. Despite the therapeutic progress, complete and
durable responses have been noted in only a few cases. The landscape of therapeutic approaches for advanced
RCC has expanded rapidly in recent years as a result of significant progress in the development of
immunotherapeutic drugs. The combination of VEGFR-targeting and immunotherapies have shown significant
clinical promise and opened the possibility of a cure for this lethal disease. However, such therapies have also
conferred additional toxicities ranging from moderate to adverse, requiring dose interruptions or reductions,
thereby limiting the efficacy. Another factor, limiting the success of VEGFR-targeting therapy of advanced
ccRCC, is the resistance which uniformly develops. Multiple studies have revealed the key role of fibroblast
growth factor-2 (FGF2) in the development of resistance in advanced ccRCC, irrespective of whether TKIs or
anti-VEGF/VEGFR2 antibodies were used as anti-VEGFR agents. Therefore, we have designed for the first time,
a novel class of dual-trap peptides (F/V traps), to block two biologically distinct pro-angiogenic pathways,
VEGFR- and FGFR-dependent, critical for ccRCC progression. By fusion of our F/V trap to Fab fragment of anti-
CD70 antibody, we have developed a new tri-specific anti-CD70-FGF/VEGF Trap fusion antibody (F/V-trap FA).
This antibody does simultaneously bind CD70, a ligand, specifically expressed in ccRCC, and neutralize both,
VEGF-A and FGF2 cytokines. It is expected that by neutralizing FGF2, a key alternative pro-angiogenic cytokine,
F/V-trap FA will prevent or at least significantly delay the development of resistance to anti-VEGF/VEGFR
therapy in advanced ccRCC. Importantly, the intra-tumoral depletion of VEGF- and FGF- cytokine families by
F/V-trap FA is anticipated to overcome side-effects arising from off-target VEGF/VEGFR inhibition seen with
systemic anti-angiogenic approaches. The proposed studies will test the hypothesis that novel bi-specific F/V-
trap FA have two major advantages over existing VEGF-neutralizing agents. By targeting the FGF/VEGF trap to
tumors, it will: (i) achieve higher intra-tumoral concentrations of the FGF/VEGF Trap; (ii) overcome FGF2-
mediated development of resistance to conventional anti-angiogenic therapy in advanced ccRCC; and (iii) limit
side-effects arising from off-target VEGFR inhibition seen with systemic anti-VEGF approaches. To test our
hypothesis and to validate the therapeutic value of F/V-trap FA, we propose the following Specific Aims: (1)
Development, identification and characterization of the leading F/V-trap FA derivative with superior FGF/VEGF
neutralizing activity; (2) To examine the anti-angiogenic efficacy of F/V-trap FA in vivo using anti-VEGFR TKI-
resistant PDX mouse models of RCC.

Public health relevance
PROJECT NARRATIVE We have generated novel tri-specific anti-CD70-FGF/VEGF trap fusion antibodies. Our preliminary data demonstrate our anti-CD70-FGF/VEGF trap fusion antibodies effectively bind either CD70 ligand on the surface of CD70 positive renal cancer cells and simultaneously bind human VEGF-A and FGF2. We hypothesize that treatment with anti-CD70-FGF/VEGF trap fusion antibodies represents a rational therapeutic strategy for patients with renal tumors.